A Novel Device for Rapid and Noninvasive Volatile Metabolite-based Screening and Diagnosis of Multiple Disease States

Project Summary/Abstract: Humans emit an array of volatile organic compounds (VOCs) as part of
normal metabolism. There are metabolic shifts in many disease states, and animals with highly sensitive
olfactory systems can be trained to identify patients with certain diseases based on their characteristic scent.
We seek to translate detection of these unique VOCs emanating through the skin to a more robust,
standardized, and mechanized platform, readily adaptable for the screening, diagnosis, and monitoring of a
variety of human disease states with distinct pathophysiologies. We hypothesize that systemic metabolic
derangements in many high burden infectious, inflammatory, metabolic, malignant, psychiatric, and
neurologic diseases can be identified via skin emissions. We will adapt a novel, portable gas chromatography-
differential mobility spectrometry (GC-DMS) device that rapidly examines volatile samples directly at the point
of care for the assessment of these skin volatile metabolite signatures. This device is highly sensitive, allowing a
comprehensive and biologically representative assessment of the landscape of human volatile emissions, is
more robust to confounding and environmental factors than many other gas sensing devices, has a long track
record of successful use in various real-world sensing applications, and is already undergoing commercial
development, which will greatly facilitate its rapid development for the skin VOC-based diagnosis of these 20
disease states. We propose further development and rigorous evaluation of this scent-based diagnostic
approach to these disease states, (1) integrating additional process analytical technologies (PATs) to ensure
instrumental accuracy and precision between samples and devices through repeated, high-volume patient
testing over time and modifying the device inlet for skin volatile analysis, (2) identifying and validating GC-
DMS signatures and the corresponding set of skin volatile metabolites that distinguish individuals with and
without each of these 20 disease states using machine learning methods, integrating automated detection of
these signatures on the GC-DMS device, and (3) developing a wearable sensor for at least one disease with a
simple volatile signature, determining the test characteristics of this wearable diagnostic device. A lack of
reproducibility is a major issue plaguing the field of volatile metabolite analysis, often due to confounding and
study design flaws. We will make every effort to minimize and eliminate any sources of confounding, bias, and
extraneous variability as we develop and evaluate this scent-based diagnostic approach, to yield generalizable
signatures for each disease state. Ultimately, successful completion of these aims will yield rapid, noninvasive
skin volatile metabolite assays for the screening, diagnosis, and monitoring of each of these diseases, with a
clear, binary (yes/no) assessment of whether the individual has evidence of one or more of these diseases,
facilitating early administration of appropriate therapeutics in these patients and mitigating the clinical
consequences of each of these diseases.

Public health relevance
Project Narrative: We seek to adapt a rapid, sensitive biosensing device that can identify specific gas molecules for the screening and diagnosis of twenty high-burden human diseases through the `scent' they emanate through the skin. Ultimately, we envision this platform can be applied to diagnosis of many other diseases, reducing diagnostic delays and allowing early administration of appropriate therapies to improve clinical outcomes in patients with these diseases.